Genetic variation and evolution of translational control in Drosophila

Project Summary
Most human diseases and traits are complex quantitative traits, involving a large number of genes, DNA
sequence variants and environmental factors, and the complex interactions among them. Despite remarkable
progress in high resolution genetic mapping, our understanding of how sequence variants cause phenotypic
variation remains incomplete. Recent studies incorporating intermediate molecular phenotypes including RNA,
protein, and metabolite abundances have facilitated functional delineation of associations between DNA
variants and complex quantitative traits in humans and model organisms. However, although mRNA translation
is a critical biological process, how natural sequence variation may lead to genetic variation in translational
control and how this level of regulatory variation can contribute to within-population and between-species
diversity remain to be understood. Using Drosophila embryos as a model system, we propose to fill this gap by
1) quantifying and mapping genetic variation of translation efficiency among embryos at multiple stages from
inbred strains of a fully sequenced and deeply phenotyped Drosophila melanogaster population; 2) mapping
genes whose cis or trans regulatory variation contributes to between-species divergence in translation
efficiency; and 3) developing a massively parallel reporter assay to systematically test effects of cis regulatory
variation on mRNA translation. These comprehensive studies, when integrated with existing data in the widely
used study population, provide a characterization of the genotype-phenotype maps in unprecedented details.
They will significantly advance our understanding of how DNA variants contribute to phenotypic variation within
and between species, including variation in disease risks among individuals in human populations.

Public health relevance
Project Narrative Differences in disease risks among individuals in human populations can be characterized as quantitative traits with a complex genetic basis. However, our understanding of how DNA variation causes phenotypic variation remains incomplete. The proposed studies will reveal how DNA variation can lead to variation in the efficiency of mRNA translation, improving our knowledge about the genetic basis of complex quantitative traits, including human diseases.